Optimizing a scalable intervention to maximize guideline-recommended diabetes testing after GDM - Diversity Supplement

ABSTRACT
Rates of gestational diabetes (GDM) are rising nationwide, particularly affecting people of color.
Despite similar rates among non-Hispanic White and Black women, Black women have more
than double the risk of developing type 2 diabetes (T2DM) after GDM as compared to White
women. This contributes to disproportionately high maternal morbidity and mortality rates in the
US, especially among Black birthing individuals. Digital health interventions show promise in
improving health, healthcare, and patient satisfaction, but tailored interventions for the Black
community are lacking, highlighting the need for inclusivity. This research project expands upon
the foundation laid by the parent award by building the evidence base for digital health
interventions, particularly for Black birthing people with GDM who face markedly elevated risk
for T2DM. This Diversity Supplement proposal for the candidate, Ijeoma Uche, MPH, focuses on
patient-centered digital interventions in diverse populations at high risk for T2DM with the
following Specific Aims. Aim 1. Conduct a comprehensive narrative review of randomized
clinical trials that have tested digital/mHealth interventions for postpartum populations at risk for
T2DM, with a focus on diverse individuals with prior GDM. Aim 2. Conduct a process evaluation
of the parent trial, including participants' engagement in and acceptability of the digital health
intervention and trial procedures. Aim 3. Convene a Research Advisory Group of Black
postpartum participants from the parent trial and clinical and health system stakeholders to
assess perspectives on the digital intervention and trial procedures, with the goal of informing
future research in this area. These activities are integral to the parent grant goals and will
provide the necessary research training, mentoring, and experience to build the candidate’s
research career as a physician-scientist focused on digital interventions for maternal health
equity.

Public health relevance
NARRATIVE Gestational diabetes rates rising, disproportionately affect people of color. We propose to study how to leverage patient-centered digital health interventions to improve care for diverse patients with GDM. Long-term goals are to prevent type 2 diabetes and other metabolic diseases in diverse maternal communities.